Nanoscale Tools for Inosine Sequencing

Project Summary
During this program, Electronic BioSciences (EBS) will fully develop and demonstrate a completely new RNA
sequencing technology capable of directly sequencing the most common product of RNA editing: inosine (I).
Cells diversify the coding potential of their mRNA and regulatory small RNAs by enzymatic conversion of
adenosine (A) to I, i.e., A-to-I editing, in which the edited base codes differently in mRNA, guides alternative
mRNA splicing, and renders miRNA and tRNA functional in cells. The current inability to directly sequence
sites of A-to-I RNA editing with quantitative readout (i.e., profile or determine their ratio within given
sequences) seriously limits the ability of researchers to fully understand this epitranscriptomic process in
disease. Thus, EBS aims to fill this technology gap by developing a single-molecule sequencing technique
capable of directly identifying the four canonical nucleotides along with I, all with high resolution and high
accuracy. In turn, such a technology development will improve the understanding of RNA function, including
the role and significance of I, to enable better diagnostics, prognostics, and therapeutics. At the end of this
Phase II effort, EBS will have developed a beta-prototype I sequencing system and demonstrated its complete
functionality and analytical capabilities for a variety of RNA types as well as benchmarked the sequencing
results against current state-of-the-art approaches.

Public health relevance
Project Narrative The technology that will be developed during this project, which can accurately call A-to-I editing sites, will be harnessed for early disease and illness detection, to provide information to decipher molecular mechanisms involved in disease initiation and progression, to monitor therapeutic outcomes and the impact on progression of the disease, and to monitor the success of novel treatments. Thus, the system we are proposing to develop, capable of directly detecting, differentiating, and sequencing A-to-I editing sites, has the potential to identify and analyze the epitranscriptomic signatures associated with viral infections, neurological disorders, Alzheimer’s disease, as well as a broad spectrum of cancer types to enable better diagnostics, prognostics, and therapeutic interventions.